Evaluation of the antitumorigenic roles of miR-122 in pancreatic cancer

PROJECT SUMMARY
The fundamental roles of microRNAs (miRs) in tumor biology and drug resistance are increasingly being
recognized. The objective of this application is to study the tumor suppressor role of miR-122, a liver-enriched
miR, in pancreatic cancer. Our published research demonstrates that the epigenetic reprogramming of
silenced miRs in pancreatic cancer can inhibit tumorigenicity and epithelial-mesenchymal transition (EMT)-
induced chemoresistance. In our preliminary studies, we found that among the miRs silenced in pancreatic
ductal adenocarcinoma (PDAC), miR-122 exhibits superior potency in suppressing tumorigenicity and PDAC-
associated EMT in vitro. Our hypothesis in this application is that miR-122 is a tumor suppressor in PDAC and
that the loss or gain of miR-122 function in genetically modified mouse models would have significant effects
on pancreatic tumorigenicity and chemoresistance. In Aim 1, we will study the role of miR-122 in mouse
pancreatic tumorigenesis. This aim is supported by our preliminary studies demonstrating that miR-122
expression is downregulated in human PDAC tissues and that miR-122 exerts anti-tumorigenic effects in
human PDAC cell lines and in orthotopic and syngeneic mouse models of PDAC. By evaluating mice with
global and pancreas-specific deletion of miR-122 and by transgenically restoring miR-122 expression in a
Kras-p53 mutant mouse model of pancreatic cancer (KPC), we will investigate the impact of miR-122 on the
initiation and progression of mouse PDAC. In Aim 2, we will investigate the mechanism by which miR-122
inhibits EMT in pancreatic cancer. Since EMT enhances drug resistance and miR-122 inhibits pro-EMT
signals, we will study the effect of miR-122 on EMT-driven genes and pathways in pancreatic cancer; this
approach is supported by our preliminary studies predicting that miR-122 inhibits the expression of the putative
EMT genes SLC39A9 and FoxP2 through RNA interference. Using biochemical approaches and transcriptomic
and metabolomic studies, we will reveal the role of miR-122 and its mRNA targets in EMT and also determine
the metabolic and transcriptomic landscapes of miR-122-regulated EMT processes in PDAC. The successful
completion of both of these aims would provide convincing evidence of how miR-122 controls tumorigenicity
and EMT plasticity in pancreatic cancer. Thus, these studies will break new ground in pancreatic cancer
research and may have a translational impact on improving therapeutic outcomes for patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because pancreatic cancer is a serious problem in the US with an estimated 60,430 new cases and estimated 48,220 deaths in people for 2021. Since the current chemotherapeutic regimens are not very effective, a novel microRNA based combination chemotherapeutic care will act as a superior treatment regimen necessary for improving survival in pancreatic cancer patients. The current R03 project will generate the necessary feasibility data toward accomplishing this goal.